Continue the NARMS retail food surveillance in the state of California

Project Summary/Abstract
Antimicrobial resistance (AMR) is a significant threat to public health in the U.S. and
globally. This project will continue the National Antimicrobial Resistance Monitoring System
(NARMS) Retail Food Surveillance in the state of California. The project’s goal of protecting
public health will be achieved by undertaking the following specific aims and activities.
First, we will continue to monitor the trends in AMR among different pathogens in retail
foods in California. We will collect retail meat and seafood samples monthly from randomly
selected grocery stores. We will isolate Salmonella, Campylobacter, E. coli and Enterococcus
from meat samples and Vibrio, Aeromonas and Enterococcus from seafood samples. Bacterial
isolates will be sent to FDA for antimicrobial susceptibility test (AST) and other analyses. We
will perform whole genome sequencing (WGS) on Salmonella, Campylobacter, and E. coli from
meat samples and Vibrio and Aeromonas from seafood samples and submit sequences to NCBI.
Second, we will conduct research to better understand AMR in retail foods. We will conduct
appropriate epidemiological and statistical analyses to characterize phenotypic and genotypic
resistance of different bacteria species in different types of meat and seafood, and associations
with seasons and years, locations, and claims of organic production and antibiotic use. Results of
the research will help to improve our understanding of emergence, persistence and spread of
AMR in and beyond retail foods. Third, we will disseminate information about AMR to
stakeholders and the public. We will develop lay publications, outreach materials, abstracts and
posters, and peer-reviewed publications. We will disseminate findings to agriculture and
aquaculture communities, research communities, veterinarians, and the public via presentations
at seminars, meetings and conferences and publications in proceedings and peer-reviewed
journals. These outreach activities will help to disseminate AMR information to stakeholders and
the public and increase public awareness of AMR in retail foods. Finally, we will participate in
NARMS retail foods conference calls, retail meat meetings and working groups.
By accomplishing these specific aims and activities, the project will continue to monitor the
trends in AMR in retail foods in the state of California and contribute to the national NARMS
Now: Integrated Data. Therefore, the project will enhance NARMS Retail Food Surveillance and
increase public awareness of AMR in retail foods. The project will also strengthen collaborations
between federal agencies and universities on surveillance, research, and detection of foodborne
antibiotic-resistant bacteria.
1

Public health relevance
Project Narrative This project is relevant to public health because the project will continue to monitor the trends in antimicrobial resistance among bacteria in retail foods in the state of California. The project is relevant to FDA’s mission in that the outcome of the project will enhance FDA’s surveillance and research of antimicrobial resistance in retail foods and strengthen collaborations between federal agencies and universities on surveillance, research, and detection of foodborne antibiotic- resistance bacteria. 1